COVID 19 Supplement: The Immunology Databse and Analysis Portal (ImmPort)

To develop a COVID-19 Data Compendium which will greatly support the COVID-19 research community by enabling secondary data reuse, large-scale meta-analysis, and interoperability across other COVID-19 data repositories.